STRESS HORMONE SIGNAL TRANSDUCTION IN ARABIDOPSIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The stress hormone abscisic acid is crucial to survival in Arabidopsis upon drought stress. Key abscisic acid signal transduction proteins have YFP fusions and have had complexes purified for analyzing signal transduction partners using mass spectrometry. This research will lead to identification of new candidate proteins that function in early abscisic acid signal transduction. The identified proteins will further be compared to guard cell specific genomic scale analyses of gene expression that have been completed using Affymetrix Genechips. Gene knockout experiments will verify the functions of the mass spectrometrically identified proteins.